Multivalent mRNA-based malaria vaccines

The heavy burden of Plasmodium falciparum and Plasmodium vivax malaria drove international efforts
to coordinate and integrate tools and programs for mosquito vector control, rapid diagnosis, and drug treatment.
Success has been significant but may be approaching a limiting boundary. The effort to develop a vaccine to
further enhance malaria control has faced many challenges. The advancement of the pre-erythrocytic-stage
RTS,S vaccine is a major accomplishment, providing the foundation for an effort that must continue to improve
efficacy and durability of vaccine-induced protection to further reduce the disease burden. In this regard, the
development of a multivalent vaccine that concurrently targets pre-erythrocytic-stage, blood-stage and sexual
stage parasites is attractive but adds complexity. The immunogenicity of each component must be maintained
while effectively driving both antibody and cell-mediated immune responses. We have utilized a recombinant
antigen plus adjuvant approach to systematically formulate an immunogenic, multi-stage, multivalent malaria
vaccine made feasible through the use of an optimized malaria-specific carrier protein, P. falciparum merozoite
surface protein 8. While successful, there are still challenges and limits to this approach considering the breadth
and nature of immune responses that are needed. Several features of the emerging mRNA vaccine technology
are extremely attractive for malaria vaccine development and may overcome challenges inherent to producing
multiantigen, multistage formulations. At the same time, the technology must be evaluated and optimized to
address issues unique to Plasmodium and malaria. In the proposed studies, we will test the hypothesis that an
mRNA-based vaccine can be optimized to concurrently drive durable, antibody-mediated and cell-mediated
protective immune responses to pre-erythrocytic and blood-stage malaria vaccine candidates. We will optimize
mRNA vaccine-induced, antibody-mediated, and cell-mediated protection to pre-erythrocytic stage parasites
using a novel P. falciparum circumsporozoite protein (PfCSP) vaccine candidate. We will design, produce, and
evaluate an mRNA-based vaccine targeting P. falciparum reticulocyte-binding protein homologue 5 (PfRh5) to
drive high titer antibodies that block merozoite invasion of erythrocytes. We will apply data on a highly protective,
Plasmodium yoelii mRNA blood-stage vaccine to the design and testing of a vaccine targeting the 19 kDa C-
terminal domain of P. falciparum merozoite surface protein 1 (PfMSP119). We will evaluate a multivalent mRNA-
based vaccine that concurrently targets sporozoites and liver-stage parasites (PfCSP) as well as blood-stage
merozoites (PfRh5 and PfMSP119). Success in the effort will determine the potential and the limitations of mRNA-
based technology for delivery of a multicomponent malaria vaccine and provide a foundation to integrate
additional targets and/or modifications to advance development of a true multi-stage malaria vaccine.

Public health relevance
The threat of disease and death due to Plasmodium falciparum and Plasmodium vivax malaria parasites remains for nearly half of the world’s population. The emerging mRNA vaccine platform has potential to address key challenges encountered in the development of malaria vaccines. This project focuses on the evaluation of mRNA technology for delivery of a malaria vaccine designed to elicit diverse responses against multiple parasite stages.